COMPUTER SYSTEMS FOR NUCLEAR MEDICINE

This project involves computer-based mathematical analysis, pattern recognition, and image processing in support of diagnostic activities in the Nuclear Medicine Department of the Clinical Center and collaborating Institutes. Applications include computerized ECG-gated radionuclide angiocardiography and myocardial perfusion scintigraphy, renal dynamics, tagged monoclonal antibody studies, and pulmonary ventilation-perfusion relationships.